COMPARATIVE STUDY OF EFFECT &EQUIVALENCE OF SIROLIMUS

Enrollment in Sirolimus 309 began in April, 1998 and closed in September, 1998. During this time, we enrolled twenty-one patients. Of the twenty-one we are continuing to follow fifteen patients, all of whom have functioning grafts. Results are consistent with what is expected in this transplant population.